A Brief Intervention to Reduce Nonsuicidal Self-Injury and Improve Functioning in Veterans

Nonsuicidal self-injury (NSSI) is the intentional destruction of one’s body tissue without suicidal intent and for
purposes not socially sanctioned. While NSSI has been understudied among Veterans, the lifetime prevalence
rate of NSSI in Veterans (16%) is actually three times higher than the general population. NSSI is associated
with risk for violence, psychiatric distress, and marked impairment in psychosocial functioning. Although NSSI
is distinct from suicidal behaviors in several important ways, NSSI is one of the strongest predictors of a future
suicide attempt identified to date. However, current interventions show limited efficacy for NSSI. There is a
critical need to identify effective treatments for NSSI to improve functioning and prevent Veteran suicide.
The proposed research aims to adapt and enhance a promising new treatment, the Treatment for Self-Injurious
Behaviors (T-SIB), to reduce NSSI in Veterans. T-SIB is a nine-session individualized treatment that
incorporates evidence-based approaches to replace NSSI with behaviors that improve psychosocial
functioning. A core component of T-SIB is functional assessment that tracks antecedents and consequences of
NSSI behaviors to identify underlying functions of an individual’s NSSI. In Aim 1, T-SIB will be adapted for use
with Veterans and enhanced to incorporate functional assessments administered via ecological momentary
assessment (EMA). EMA reduces retrospective recall bias and can capture NSSI behaviors in-vivo. A
successive cohort design including two cohorts of Veterans (n = 5 each) will be used to refine the T-SIB
protocol. Qualitative and quantitative data will be reviewed after each cohort to make successive modifications.
In Aim 2, the feasibility and acceptability of T-SIB will be evaluated with a pilot randomized controlled trial
(RCT). Veterans with NSSI (N = 40) will be randomized to T-SIB enhanced with EMA or treatment as usual
(i.e., safety planning and referral to mental health services). Primary outcomes will include measures of
feasibility and acceptability. Additional measures of NSSI and psychosocial functioning will be administered at
baseline, posttreatment, and a three-month follow-up. In Exploratory Aim 3, multilevel modeling will be applied
to EMA functional assessments to examine intra- and inter-individual changes in antecedents, consequences,
and NSSI functions over a nine-week period. Study aims will support future investigator-initiated research (IIR)
applications to conduct a fully powered RCT to test the efficacy of T-SIB for Veterans.
The candidate is a postdoctoral fellow in the Mid-Atlantic Mental Illness Research, Education and Clinical
Center (MIRECC) at the Durham VA. The training aims associated with this proposal include: 1) gain expertise
in treatment development and clinical trial methodology; 2) acquire skills in advanced modeling of longitudinal
data; and 3) engage in professional development to prepare for a successful career as a VA clinical
investigator. These objectives will be supported by the candidate’s mentorship team of NSSI experts, including
the original developer of T-SIB, and VA investigators with experience conducting clinical trials emphasizing a
recovery framework. The research and training associated with this CDA-2 will prepare the candidate to
acquire critical content and methodological expertise to competitively apply for IIR funding and transition to
independence as a VA investigator. The candidate’s long-term goal is to build a career as a VA investigator
committed to identifying and implementing interventions that improve psychosocial functioning and prevent
self-directed violence among Veterans.

Public health relevance
Nonsuicidal self-injury (NSSI) is the intentional destruction of one’s body tissue without suicidal intent and includes methods such as cutting, burning, or scratching oneself. Although NSSI is different from behaviors that have suicidal intent, NSSI is a risk factor for future suicide attempts. Individuals report engaging in NSSI for a variety of reasons such as emotion regulation (e.g., to feel less angry) or for interpersonal reasons (e.g., to end an argument). NSSI is common among Veterans but there are few effective treatments. The proposed study would develop a psychotherapy treatment specifically for Veterans with the aim of reducing NSSI. This treatment will also include mobile technology to allow for tracking of NSSI behaviors outside of therapy sessions. Knowledge generated by this research could be used to improve treatment options for Veterans engaging in NSSI and prevent Veteran suicide.